Exxact Computer System for Deep Learning, Molecular Dynamics and NMR Processing

Project Summary
Per PA-20-272, the Project Summary is not required. However, grants.gov requires a document
to be uploaded in this field. This is a placeholder.

Public health relevance
Project Narrative Per PA-20-272, the Project Summary is not required. However, grants.gov requires a document to be uploaded in this field. This is a placeholder.